Defining the influence of RA genetic susceptibility factors on T cell antigen specificity and functional state

Project Summary
During this past R01 funding period, we have mapped causal effects within the MHC region to
specific HLA-DR binding groove amino acid sites, identified >100 rheumatoid arthritis (RA) non-
MHC risk alleles across the genome, and have demonstrated that these alleles are largely
within CD4+ T cell regulatory elements. If we could define the genetic mechanisms
underpinning RA susceptibility, then it may be possible to define therapeutic strategies to
abrogate or prevent RA. Central to this is defining the key T cells involved in mediating disease
susceptibility – both in terms of their unique TCR sequence features and their pathogenic cell
states. Here, we hypothesize that HLA-DR risk alleles act within the thymus to favor selection of
“sentinel TCRs”, and that when autoantigens are presented to sentinel TCRs, risk alleles within
T cell enhancers alter T cell specific gene regulation, which enables naïve T cells expressing
sentinel TCRs to transition into a pathogenic state. We define “sentinel TCRs” as those
receptors that bind to citrullinated peptides and trigger the initial autoimmune response. Risk
alleles in T cell promoters and enhancers alter regulation of critical T cell genes that regulate the
transition of T cells into pathogenic states. Hence, a T cell with a rare “sentinel TCR” can, under
the right conditions, trigger the initial autoimmune response, drive a spreading immune
response, and initiate persistent joint inflammation. But, the key pathogenic T cell states,
sentinel TCRs, and the action of specific causal regulatory T cell alleles are not yet fully defined.
Repertoire sequencing to define TCR sequences in blood and tissue, single cell analyses to
resolve T cell states, and genetic engineering to interrogate causal T cell alleles and genes
represent exciting methodologies that our lab has developed expertise in. In this proposal we
seek to build support for this model. First, we will demonstrate that HLA class II HLA RA risk
alleles alter TCR repertoire to harbor “sentinel TCRs”, using TCR and genotype data from 300
healthy individuals. Next, we will use polygenic RA risk models to define the key T cell states
that RA risk alleles influence with single cell data on surface markers and transcripts in the
same 300 individuals. Finally, we will define the molecular mechanisms of non-coding alleles
using genomic editing in CD4+ T cells; to this end we will develop and apply strategies to edit
primary T cells, sequence DNA to confirm the presence of the desired edit, and obtain RNA and
ATAC sequencing data to understand the impact of the edit and confirm the functionality of non-
coding alleles.

Public health relevance
Project Narrative Now that we have identified the key genetic loci that modulate rheumatoid arthritis (RA), we seek to define the mechanism by which these loci cause disease. Here we explore an innovative model of genetic susceptibility that links the role of the MHC and alleles within T cell regulatory regions. If our strategy is successful, it will pave the way to unlocking new therapeutic strategies to treat RA and possibly cure it.